GENETICS OF FAMILIAL MEDITERRANEAN FEVER

Familial Mediterranean Fever (FMF) is a rheumatic disease caused by a single autosomal recessive gene. Patients with this disorder experience acute attacks of fever, arthritis, abdominal pain, and/or pleurisy; some develop amyloidosis as a long-term complication. The biochemical lesion in FMF, as well as the chromosomal location of the FMF gene, is presently unknown. This project is designed to find the chromosomal location of the FMF gene, and ultimately the gene itself. We have identified 55 Israeli families in which more than one individual suffers from FMF. Blood samples have been obtained from 347 individuals from these families, and Epstein-Barr virus-transformed lymphoblastoid cell lives have been established for each individual. Using cell line DNA from a particularly informative subset of these families, initial mapping studies have been undertaken by probing Southern blots with highly polymorphic DNA markers. To date we have excluded approximately 10% of the human genome as a potential site for the FMF gene. Large areas of exclusion have been established on chromosomes 1 and 9; smaller exclusionary area have been established on chromosomes 4 and 22. More importantly, we have found a DNA marker which shows modest evidence for linkage to the FMF gene (LOD=1.3 for Theta=0.1). From the data obtained thus far, the odds in favor of linkage to this marker are 20:1; a 1000:1 ratio is required for proof of linkage. Additional studies are in progress to determine whether this marker is in fact linked to the FMF gene.